Implementing and sustaining Critical Time Intervention (CTI) in case management programs for homeless-experienced Veterans

Background: The VA Grant and Per Diem case management (GPD-CM) program provides six months of case
management for homeless-experienced Veterans (HEVs) undergoing housing transitions. At present, no
specific case management paradigm is required in the GPD-CM program, resulting in practice variation across
sites. National implementation of Critical Time Intervention (CTI)—an evidence-based, structured, and time-
limited case management program for HEVs experiencing housing transitions—would standardize and
improve case management in the GPD-CM program. Implementing CTI in routine care settings requires
balancing the need for CTI fidelity with adaptations to fit the diverse programs serving this population.
Moreover, some organizational contexts may require more intense and tailored supports to implement CTI.
Objectives: We propose to implement CTI at 32 GPD-CM sites. To implement and sustain CTI across these
sites, we will use the Replicating Effective Programs (REP) implementation bundle to enable sites to achieve
fidelity to CTI’s core components, while accommodating adaptations to fit the diversity of GPD-CM settings
and contexts. We will cluster randomize half the sites to also receive 9 months of external facilitation
(“enhanced REP”), an established process of providing tailored support for providers and leaders in the ir
efforts to adopt and incorporate EBPs into their routine care processes. Our Specific Aims are to: 1) Use REP
and enhanced REP to support the implementation and sustainment of CTI in 32 GPD -CM sites; 2) Compare, in
a type 3 hybrid implementation-effectiveness trial, the impacts of REP vs. enhanced REP on CTI fidelity and
sustainment, quality metrics (focused on housing stability and hospitalization rates), and costs and return-on-
investment; and 3) Generate two key products for program partners—a business case analysis and an
implementation playbook —to support continued spread and sustainment of CTI in the GPD -CM program.
Methods: We will use a CTI training and technical assistance package developed and refined in our QUERI-
VISN Partnered Implementation Initiative (PII) Start-up to implement CTI in 32 GPD-CM sites. We will use
REP to support CTI implementation at all 32 sites. Half of these sites will also receive 9 months of external
facilitation (EF, as part of enhanced REP), building on our EF experiences and materials developed in the PII
Start-up. To compare the impacts of REP vs. enhanced REP, we will conduct a cluster randomized type 3
hybrid trial. We will use a rollout design in which randomization occurs at two levels: when impleme ntation
begins (three cohorts) and the implementation strategy (REP vs. enhanced REP). We will use permuted block
randomization to balance key site characteristics among sites receiving each of these strategies across cohorts.
We will use mixed methods to assess the impacts of REP vs. enhanced REP. As fidelity to CTI influences its
effectiveness, fidelity to CTI is our primary outcome, followed by sustainment, quality metrics, and costs. We
hypothesize that enhanced REP will have higher costs than REP alone, but will result in stronger CTI fidelity,
sustainment, and quality metrics, leading to a clear business case for enhanced REP. This work will lead to
products that will support our program partners in spreading and sustaining CTI in the GPD-CM program.
Significance: At present, no specific case management paradigms are required in the GPD-CM program,
resulting in significant practice variation across sites. Implementing CTI in this program is a unique
opportunity to reduce clinical variation across sites, improve housing stability and decrease hospitalizations
among HEVs, and further VA Network Directors’ priorities to improve the uptake of strategies to address
health disparities and Veteran social determinants of health.

Public health relevance
The VA Grant and Per Diem case management (GPD-CM) program provides six months of case management for homeless-experienced Veterans (HEVs) undergoing housing transitions. At present, no specific case management paradigm is required in the GPD-CM program, resulting in practice variation across sites. This Partnered Implementation Initiative (PII) Full Award proposes to implement Critical Time Intervention (CTI)—an evidence-based, structured, and time-limited case management practice—at 32 VA GPD-CM sites. We will use the Replicating Effective Programs (REP) implementation bundle to support CTI implementation at all 32 sites. Half of these sites will also receive 9 months of external facilitation (enhanced REP) as additional support for CTI implementation. In a type 3 hybrid trial, we will use mixed methods to examine the impacts of REP versus enhanced REP. Using our trial data, we will develop a business case analysis and implementation playbook for our program partners to support continued CTI spread and sustainment in the GPD-CM program.